Using Drosophila Olfactory Navigation to Study Principles of Motor Encoding

Project Summary/Abstract
Goal directed actions are often composed of shorter stochastic motor elements. How motor circuits are
organized to translate a sensory-determined goal into a set of stochastic motor actions is unclear. Here I
propose to use olfactory navigation behavior in the genetic model organism Drosophila melanogaster to
identify the circuitry and computational basis of motor control in a complex, goal-oriented task.
Fly olfactory navigation is a highly robust behavior composed of shorter, stochastic motifs. Olfactory navigation
involves three stages. At baseline, flies explore their environment in a stochastic fashion. When presented
with an appetitive odor, flies orient and run upwind. At odor offset, flies complete a search-like behavior,
consisting of high angular velocity movements. Each phase has both reliable components (upwind orientation,
increased angular velocity) and stochastic components (the precise timing of turns and runs). Our lab has
developed a high-throughput paradigm in which these three phases can be elicited repeatedly either though
presentation of an attractive odor, or through presentation of a fictive optogenetic odor. The large datasets I
can obtain with this paradigm are amenable to both computational and genetic analysis.
In my first Aim, I will perform a computational analysis of olfactory navigation behavior, identifying the
timescales at which behavior is modulated following odor presentation or withdrawal, and decomposing fly
trajectories into a series of behavioral motifs. Based on my motif analysis I will construct a Markovian model
that seeks to reproduce the complex statistics of navigation behavior, and to understand how the stochastic
elements of navigation are concatenated to produce reliable goal-finding. In the second Aim, I will use genetic
silencing and activation to identify descending neurons (DNs) that contribute to the behavior motifs and
temporal structure identified in the first Aim. DNs carry motor information from the brain to the ventral nerve
cord, similar to neurons in the vertebrate that carry information from the brain to the spinal cord. This analysis
will allow me to obtain a fairly complete circuit map of the motor circuitry the contributes to olfactory navigation.
Finally, in my third Aim, I will determine what features of sensory and motor information are encoded in the
activity of particular DNs. Currently, two views of motor encoding exist in the fruit fly. Some studies support the
notion that DNs relay motor information depending on behavioral context, while others suggest they encode for
specific movements, regardless of sensory driver. Olfactory navigation, composed of epochs of varying
stimulus and behavioral goal, is poised to determine how movements of different sensory origin or behavioral
context are encoded in motor circuitry. Using a closed loop behavioral apparatus, I will image from select DNs
during olfactory navigation and correlate activity with both behavioral motifs and navigational phase. Together,
these experiments will help to uncover principles of motor encoding, which could aid in understanding how the
brain is able to regain motor control after injury.

Public health relevance
Project Narrative Motor circuity is built to successfully construct repeatable behaviors, like a simple hand reach, from a series of smaller, more variable movements. How these stochastic components are combined to properly execute motor behaviors remains unclear. This project uses the simpler nervous system of the fruit fly to obtain a complete circuit understanding of how a goal-oriented behavior—the search for an attractive food odor— is encoded and produced by descending motor circuitry.